Core C: Prevention and Implementation Sciences Core

Modified Project Summary/Abstract Section

The Prevention and Implementation Sciences (PAIS) Core (Core C) is dedicated to supporting rigorous, high-impact team science and accelerating the highest caliber HIV prevention, behavioral science, and implementation science research in support of NIH research priorities and the Ending the HIV Epidemic Initiative (EHE). In the current funding cycle, PAIS Core developed a successful service center model, launched the Study Management and RetenTion System (SMART) study platform, and co-developed the Planning for Success grant writing initiative. The Core will continue these successful initiatives and will develop new services to advance prevention science objectives. A goal of the Core is to provide training and support in implementation science to bridge implementation chasms that impede progress toward reaching the EHE goals. The proposed Aims expand beyond traditional sociobehavioral sciences to integrate novel technologies (e.g., mHealth), theoretical advancements (e.g., implementation frameworks), and web-based platforms for service provision. Collectively, these expansions will enhance the Core’s impact and promote the CFAR priority of conducting groundbreaking, transdisciplinary science, mHealth and implementation science approaches, grounded in sociobehavioral sciences, offer promising avenues to achieve EHE and NIH research priorities by supporting scale-up of successful interventions. Scaling-up evidence-based interventions (e.g., PrEP, HIV testing) through traditional physical access channels and in-person interventions will be challenging. mHealth approaches provide rapidly scalable solutions, and Emory CFAR Members will benefit from the Core’s apps and survey support services shortening the time from concept to funded research. Implementation Science approaches offer critical frameworks and methods to elucidate the determinants of implementation and to scale-up mHealth and other efficacious approaches vital to achieving EHE goals. They also hold great promise for promoting healthcare access through efficacious interventions in the community. A new training program, Collaboration for Success (CfS), will make PAIS Core services more accessible through a series of virtual and in-person meetings and by making datasets available to facilitate novel research and to strengthen grant applications. Building on the Core’s strengths in sociobehavioral science methods and in collaboration with CFAR Cores and SWGs, the PAIS Core will support rigorous transdisciplinary HIV research through the following specific aims. Aim 1. Facilitate cutting-edge technology-based HIV prevention and implementation science research. Aim 2. Support the rigorous application of IS approaches in CFAR and NIH proposals and research. Aim 3. Enhance access to sociobehavioral and biomedical HIV prevention research resources.